Disease-Modifying Genes in Huntington's Disease

Disease-Modifying Genes in Huntington's Disease: HD is a devastating neurodegenerative disorder with a long,
costly, debilitating course to premature death, ~15 yrs after clinical diagnosis. There is a dire need for effective
therapies to alleviate the suffering and cost to the individual, family and society. The HD mutation in HTT is an
expanded CAG trinucleotide repeat whose length is the main factor determining the timing of clinical onset.
Although it is often assumed that the length of polyglutamine in huntingtin drives the rate of pathogenesis leading
to HD onset, our data from HD subjects do not support this conclusion. Disease-associated HTT alleles with the
same pure CAG repeat size may produce different-sized polyglutamine tracts due to variable glutamine-encoding
CAA codons, with no commensurate hastening in HD onset due to extra glutamines. Rather, age-at-onset is
best explained by a property of the pure CAG repeat separate from its coding potential. We have discovered that
HD age-at-onset is modified by genetic variation at 6 loci that encode genes involved in a variety of DNA
maintenance processes. These genetic modifiers, in both humans and mouse models, implicate somatic
expansion of the CAG repeat rather than encoded polyglutamine as the factor determining age-at-onset. By
contrast, symptomatic progression shows at best a weak correlation with CAG repeat size, while duration of
manifest disease (i.e., the time from motor diagnosis to death) is independent of CAG repeat length, suggesting
that other factors are paramount in determining pathogenesis from onset to death. Overall our findings point to
HD as comprising two distinct components: 1) length-dependent somatic expansion of the CAG repeat up to and
above a threshold length (rate driver) that then engages toxicity and 2) as yet uncertain mechanism(s) by which
the somatically expanded repeat triggers damage when the threshold length is reached (toxicity driver). The
nature of the toxicity driver(s) is not yet unequivocal. An effect on huntingtin by above-threshold polyglutamine
(rather than continuous length-dependent toxicity) is both attractive and consistent with the effects of long CAG
repeats in model systems, but other mechanisms that act at the transcriptional or RNA level have also been
suggested as causative. The success of our human genetic strategy has begun to provide new targets for
therapeutic interventions to delay or prevent HD onset. In this renewal, we will identify additional rate modifiers
to more fully delineate the process of somatic CAG expansion in humans and will extend our strategy to discover
modifiers of manifest disease that implicate the nature of the toxicity driver or its damaging consequences. The
identification of novel targets, implicated by the natural variation in biological processes ongoing in HD subjects
themselves, will provide a firm foundation for developing pharmaceutical interventions that push those processes
even farther, toward a strong therapeutic benefit. Thus, the promise of this grant is a new and powerful route to
fulfilling the greatest need of both premanifest and manifest HD subjects and their families: effective treatments
to block or delay onset and progression of the disease.

Public health relevance
Huntington’s disease (HD), with its single genetic cause, an expanded CAG repear in HTT, is an inherited neurodegenerative disorder that devastates entire families. This project uses genetic and genomic approaches to uncover other genes that significantly influence when diagnosable symptoms emerge and how rapidly they worsen. Using a combination of human HD disease subject sample collections, induced pluripotent stem cell lines and neuronal cells derived from them, we will home in on the precise genes and biological pathways that influence the distinct HTT CAG-initiated disease processes that lead to onset and worsening of disease, respectively. We will thereby generate the knowledge and experimental resources to support therapeutic development for the first time based upon targets already validated to alter the rate of HD in humans.